Dissemination Core

Point of Care Technologies for Nutrition, Infection and Cancer for Global Health (PORTENT)
5.0 Dissemination Core
Abstract
The PORTENT center represents a novel and rigorous approach to the development, deployment, and
commercialization of point-of-care technologies for global health. With the COVID-19 pandemic we have
seen the impact that accessibility to POC technologies can have and conversely the negative impact of their
absence. As we have outlined in our preliminary needs assessment in the Overall section the opportunity for
impact in areas with weaker accessibility to traditional healthcare is even greater.
While the opportunity is greater, so is the challenge. Needs assessment, the path to commercialization,
regulatory structures, training needs, and knowledge dissemination are all different than they are domestically.
To address this, we have assembled a dissemination core that is precisely designed to enable users to address
these challenges. Our dissemination core comprises of four key flagship elements that make it unique and
able to address this challenge: (1) a comprehensive approach to needs assessment that will draw on our
worldwide expertise and experience to develop an annual needs assessment consensus that will inform our
technology development efforts, (2) The establishment of a “Global Health Point-of-Care Diagnostics Lab to
Market Accelerator” that will provide commercialization and tech-to-market support for the PORTENT projects
specific for their technology and settings, (3) Unique training opportunity for healthcare workers, users and
technology developers on the use/creation of PoC devices enabled by our specialized AidSmart! App and
unique facilities, and (4) Dissemination through Knowledge transfer workshops that will broadly share the
outcomes with the PORTENT efforts with the global health and developer community. By year 5 of PORTENT,
we expect that at least 15 teams will engage in the Lab-to-Market accelerator program, we will train at
least 30 health care workers from LMIC countries in the use of point-of-care technologies, and we will
provide at least 20 clinical rotations for technology developers at one of our clinical sites. This integrated
core could become a model for global health diagnostic technology development and have impact well beyond
the PoCTRN program.